SOLID PHASE SYNTHESIS OF A COMBINATORIAL LIBRARY

Solid Phase Sciences Corporation (SPSC) proposes to produce a library of substituted acridine and pyridine based heterocycles. The library will consist of 5-10 milligrams each of a total of 384 compounds. SPSC will accomplish this by utilizing it's novel high-loading support and commercially available solvent delivery robot. Specifically, libraries will be made off of this high-loading support to separate the desired products from undesired starting material. A liquid handling robot will be used to add reagents and solvents. The goal of the Phase I effort will be to integrate the use of this high-loading support in solid phase synthesis with automated liquid handling into one automated system to produce a library composed of a series of acridine and pyridine based heterocyclic compounds for general screening.